Leveraging inter-individual differences in walking pain and impairment to elucidate whole-person mechanisms of knee osteoarthritis

Project Summary/Abstract
Knee osteoarthritis (OA) is a common and debilitating condition, affecting millions in the United States of America.
From 1990 to 2020, OA ranked as the 14th highest cause of age-adjusted years lived with disability and is a
serious disease due to disability, which increases mortality. Although the impact of knee OA on the population
level is tremendous, there are significant inter-individual differences in pain and functional impairment. Weight-
bearing, movement-evoked pain experienced during walking ranges from minimal to severe. Some patients
maintain movement, experiencing a range of pain intensities, while others are immobilized due to pain. Factors
contributing to inter-individual differences are unclear, in part due to the lack of studies examining the “whole
person,” including biological, psychological, and social factors ranging from the knee and nervous system to
social engagement. Identifying biopsychosocial mechanisms underlying inter-individual differences in pain and
movement is a critical unmet need in knee osteoarthritis. These mechanisms represent opportunities for novel
treatment targets, personalized treatments, and an avenue to improve overall health by maintaining or improving
physical activity known to reduce morbidity and mortality. This application’s objective is to elucidate “whole
person” biopsychosocial mechanisms of movement-evoked pain and pain limitations on function in knee OA.
Informed by a theoretical framework of movement-evoked pain, preliminary data demonstrate that sensory
processing and pain prediction factors contribute to walking pain in knee OA, measured using the 6-minute walk
test (6MWT). Overlapping and distinct factors predicted functional impairment, defined as distance walked on
the 6MWT. Using concurrent ambulatory brain imaging and gait biomechanics during 6MWT, patterns of pain
with walking and pain-limiting walking performance emerged. These preliminary data suggest that the lab-based
approach to understand fundamental “whole-person” mechanisms of movement evoked pain and functional
impairment shows promise. In the proposed observational study, the first specific aim is a comprehensive data
collection in a large sample of knee OA patients, including knee joint MRI and detailed biomechanics
assessments. The second aim will identify key factors associated with knee pain increases during walking on
the 6MWT and following exercises emulating initial PT evaluation. The third aim will identify key factors
associated with reduced function on the 6MWT and identify how pain and gait relate over time during physical
activity. Parametric hypothesis testing and data-driven, machine-learning methods will be applied to this rich
dataset. Pain prediction mechanisms are anticipated to play a large role and represent a novel treatment target.
Overall, identification of key factors underlying inter-individual differences in movement-evoked pain in knee OA
will reduce pain, functional impairment, and morbidity and mortality, broadly aligning with the mission of the NIH
and specifically the goal of NIH HEAL Initiative to enhance pain management.

Public health relevance
Project Narrative Pain with walking is a hallmark of knee osteoarthritis, and yet it is not well understood on a “whole-person” level. Through holistic data collection and advanced analytic approaches, this observational study will identify biopsychosocial factors that contribute to inter-individual differences in walking pain and pain limiting walking with the hypothesis that neural processes play a key role. These results will identify new therapeutic targets to maintain or improve physical activity in patients with knee osteoarthritis, leading to better outcomes of physical therapy and improved overall health and well-being.